AZT, DIDANOSINE AND NEVIRAPINE VS COMBINATION AZT AND DIDANOSINE

To examine whether the triple drug combination of AZT, ddl, and nevirapine offers advantage to the two drug combination of AZT and ddl.